Tissue systems biology of immune dysregulation in aging by single cell spatial metabolomics

The immune system changes with age and gradually leads to incompetent immune responses against
pathogens. Immune cells experience senescence, an irreversible cell cycle arrest, and secrete senescence-
associated secretory phenotype (SASP) factors, causing pathological alterations of spatial organization and
cell types in the germinal centers (GCs) of lymphoid organs. GC structures are impaired in the elderly
population, reducing antibody production in aging individuals. B cell immunometabolism is crucial to meet the
energy needs of rapid proliferation, somatic hypermutation, and affinity-based selection in GCs. However, the
coordination of metabolic pathways in T follicular helper cells (TFH) and GC B cells is still not clearly
understood. There is a critical need to decipher the TFH-dependent B cell immunometabolism at the single cell
level in GCs for identifying aging-associated molecular defects. Thus, this project will leverage the recently
developed spatially resolved metabolic profiling framework (3D-SMF) that maps the CD4+ T cell and B cell
subsets and their metabolic correlates in native lymphoid tissues. Our long-term goal is to generate single cell
metabolic insights of TFH-dependent B cell development in GCs of elderly individuals compared to young
ones. The goal of this project is to define spatially resolved B cell immunometabolism pixel-by-pixel in fixed
human tonsil and lymph node tissues. We hypothesize that unique metabolic programs of cellular senescence
and SASP factor diversity are regulated by lipid metabolism events, causing age-dependent unique immunity;
and these programs are distinctively potent in subtypes of secondary lymphoid organs in younger aged groups
compared to the older ones. The rationale for this hypothesis is based on the 3D-SMF data showing depletion
and enrichment of fatty acids in GCs located in native tonsil tissues. The central hypothesis will be tested by
pursuing two specific Aims. Aim 1 will provide a deeper understanding of the lipid-associated
immunometabolism in TFH cells and B-cell subsets (naïve, GC B cells, and plasma cells) in human tonsil
tissues. Aim 2 will define how the metabolic network modeling of TFH and B cell subtypes and overall cell
composition differs in lymph nodes in comparison to tonsil tissues. To accomplish these Aims, 3D-SMF and
multiplexed enzyme profiling will be used to analyze B cell immunometabolism using a metabolic network
comparison of B cell subsets in native tonsils and lymph nodes. This project builds an interdisciplinary team
integrating experts from single cell biotechnology, bioengineering, inflammation in aging, metabolic modeling,
and bioinformatics. The proposed application is innovative because it uses cutting-edge technology to define
spatial metabolomics and proteomics of tonsil and lymph node tissues without dissociation protocols and shifts
from the traditional focus on isolating T cell and B cells from their native microenvironment to study immune
defects in aging. This research is significant because it defines TFH-dependent B cell immunometabolism in
lymphoid tissues to decipher single-cell metabolic fingerprints of immune dysregulation in aging.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it will build a foundational metabolic understanding of tonsils and lymph nodes, common immune organs playing a pivotal role in immunity, and their structure and functional alterations during aging. This proposal leverages cutting-edge spatial metabolite and protein profiling technology to define chemical regulators and defects in controlling a key cell type, B cell, in human tissues from diverse aged donors while simultaneously testing physiologically relevant differences between anatomically distinct T cells and B cell subtypes with unique functional changes in aging. Thus, the proposed research is relevant to the NIA’s mission of obtaining new knowledge on how the immune system is dysregulated in the elderly compared to young individuals through tissue-level molecular studies.